Stem cell regulation during development and whole-body regeneration

PROJECT SUMMARY
Although the early embryos of humans and other vertebrates have pluripotent cells that can differentiate into all
cell types of the animal, these flexible cells are absent in adults. In contrast, many invertebrate animals
maintain pluripotency beyond embryogenesis, and harbor adult pluripotent stem cells (aPSCs) that enable
whole-body regeneration. The long-term goal of the PI’s research program is to obtain a mechanistic
understanding of how pluripotent stem cells are made, retained, and regulated in vivo such that they can
regenerate any missing cell type in an adult animal. Across 750 million years of animal evolution, cells operate
on conserved principles, thus invertebrate species that maintain pluripotent stem cells in adult animals can
serve as informative model systems. The overall objective in this application is to identify the molecular and
cellular mechanisms that regulate aPSCs called “neoblasts” in the acoel Hofstenia miamia. Hofstenia can
regenerate any missing cell type and is amenable to high-throughput functional studies of regeneration. The
rationale for choosing a new model system over planarians, the more established system for studying
neoblasts, is that Hofstenia produces manipulable embryos in large numbers, allowing the use of methods
such as transgenesis, currently unavailable in planarians, to answer outstanding questions about neoblast
biology. The experiments proposed here will combine lineage-tracing methods with functional genomics
approaches to uncover and characterize critical regulatory control of pluripotent cells, asking three major
questions: 1) Which genome-wide chromatin regulatory landscapes and transcriptional programs control the
establishment and retention of pluripotent cells in embryos? 2) Which chromatin regulatory mechanisms and
cellular dynamics enable neoblasts to achieve pluripotency during regeneration? 3) Which cellular mechanisms
allow neoblast progeny to assemble into functional tissues? Isolation of the neoblast lineage followed by
transcriptome and chromatin profiling in Hofstenia embryos, techniques that have been feasible in the
applicants’ hands, will be utilized to identify chromatin landscapes and their regulators. Transgenesis, a
technique recently developed in Hofstenia by the PI, will be used to specifically label neoblast subpopulations
to trace their fates. Live imaging of differentiating neoblast progeny and functional studies of cell adhesion
genes will be used to study how fate decisions are integrated with cell adhesion to enable assembly of newly
regenerated tissues. In all research directions, RNA interference or CRISPR-Cas9 gene editing, two
approaches that are feasible in this system, will be used to study gene function. This proposal is innovative in
its use of a novel model system that has enabled new approaches, including the labeling and isolation of
specific cell lineages, for studying long-standing questions about stem cell biology and regeneration. This
project will reveal basic molecular and cellular principles for the regulation of pluripotent cells that have the
potential to inform the development of new applications in human regenerative medicine.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because it will identify molecular and cellular mechanisms for how pluripotent stem cells can be established in embryos, retained into adulthood, and then regulated for the formation of differentiated cell types in the context of a whole animal. An understanding of these mechanisms is essential for progress in human regenerative medicine and therefore relates to the NIH’s mission to acquire fundamental knowledge about living systems that can be applied to human biology to reduce disability.